Deciphering epigenetically-regulated pathways to improve targeted therapy for invasion and metastasis in head and neck cancer

PROJECT SUMMARY
Head and neck squamous cell carcinoma (HNSCC) is the sixth leading cause of cancer-related mortality, with
most deaths attributable to metastasis and treatment failure. Unfortunately, our understanding of the pathways
that underlie invasion and metastasis is incomplete, but some hints were uncovered by our recent single cell
sequencing analyses which revealed that many HNSCC tumors contained cells that were neither fully epithelial
nor fully mesenchymal, but were in a unique, hybrid epithelial-mesenchymal (hybrid-EM) state. The presence
of hybrid-EM cells was more predictive of poor response than smoking history, and functional studies established
hybrid-EM as a key driver of invasion and metastasis. Together, these observations establish hybrid-EM as a
central pathway in HNSCC progression. However, hybrid-EM marker proteins are not druggable, so it remains
challenging to therapeutically target this state. Cell states like hybrid-EM are regulated by a variety of
mechanisms, but super-enhancers, in particular, have been identified as essential for maintaining cell identity.
We therefore targeted super-enhancers in HNSCC using the BET inhibitor JQ1 and observed a reduction in
HNSCC invasion of ~2-fold and a suppression of hybrid-EM. This result was encouraging, but effect size was
modest due to the indirect and non-specific mode of action of JQ1. We hypothesized that if we could elucidate
genes regulated by super-enhancers in HNSCC, we could identify molecular pathways that are more directly
and specifically involved with invasion and metastasis and uncover more potent targets. Our initial experiments
found that super-enhancers regulate cholesterol biosynthesis genes in hybrid-EM cells and that their knockdown
(KD) robustly disrupts hybrid-EM phenotypes, with a >2000-fold and >8000-fold reduction in invasion upon KD
of two mevalonate synthesis genes. Importantly, the protein products of many of the cholesterol genes we
identified can be inhibited by commercially available small molecules. Indeed, we found that statins, which inhibit
cholesterol biosynthesis, potently inhibit invasion (>10-fold reduction). These data provide strong support for our
original hypothesis. We now propose to use CRISPRi to systematically investigate the role of cholesterol
metabolism in invasion in HNSCC using sophisticated in vitro and in vivo models (Aim 1). In Aim 2, we will
evaluate 9 small molecule inhibitors of cholesterol biosynthesis in cell lines, patient-derived organoids (PDOs),
and in vivo pre-clinical models. Finally, in Aim 3, we will identify the full regulatory network of super-enhancers
that control hybrid-EM, specifically focusing on Brd2-4 which are inhibited by JQ1. For these experiments, we
will use single cell approaches to account for tumor heterogeneity and thereby uncover additional pathways
beyond cholesterol biosynthesis that direct invasion and metastasis. Together, these experiments will provide
critical insights into how super-enhancers regulate hybrid-EM, while exploring the possibility that by targeting the
super-enhancer-regulated cholesterol biosynthesis pathway using existing FDA-approved drugs, we could
circumvent a length drug development process and move quickly into human trials.

Public health relevance
PROJECT NARRATIVE Although progress has been made in head and neck squamous cell carcinoma (HNSCC), the mainstays of treatment continue to be surgery, radiation, and chemotherapy -- unfortunately, most patients have poor prognoses, with spread to lymph nodes and poor responses to treatment representing two of the most common reasons patients die from this disease. We recently found that some tumors cells are in an unusual transcriptional state called the “hybrid epithelial-mesenchymal” (hybrid-EM) state, and these hybrid-EM cells are primarily responsible for invasion and metastasis in HNSCC. Our initial forays investigating how this state is regulated revealed that the genes involved in producing cholesterol also play a role in HNSCC invasion, and we therefore propose to 1) test drugs targeting cholesterol pathways in sophisticated models, 2) find other cholesterol genes that could be targeted to treat HNSCC, and 3) apply the same strategy that we used to identify the cholesterol pathway to find other pathways important in invasion.